Research Training Fellowship in Complementary and Integrative Healthcare

ABSTRACT
Building on our strong training track-record, this T32 competitive renewal application, responding to PA-20-
142, requests funding for years 16-20 of the UNC Complementary and Integrative Healthcare (CIH) Research
Training Program, to continue training promising pre- and postdoctoral young investigators in research
methodology for future academic career success in CIH research. The goal of this T32 Research Fellowship is
to cultivate talented, productive, well-trained, independent researchers at both the pre and post-doctoral level
as CIH research leaders in investigating efficacy, effectiveness, mechanisms of action, and implementation of
clinical integration of complementary therapies and integrative health-care approaches. Our program highlights
an interdisciplinary array of research topics, methodologies and faculty mentors, providing rigorous training in
research methods to facilitate exploration of mind-body techniques and CAM natural-product/nutritional
therapies and their applications in health promotion, chronic pain, metabolic syndrome, and other high-impact
conditions, with emphasis on enhancing access to CIH care in at-risk, underserved populations.
The Fellowship provides a comprehensive curriculum featuring: 1) five post-doctoral positions with trainee
participation in formal advanced training over two to three years involving research methods, mentoring and
biostatistics, including course work in the UNC School of Public Health; 2) two predoctoral trainee positions
(expanded from one position), with trainees selected from public health, nursing and other health-professions
schools for their faculty-matched interest in CIH clinical research; 3) faculty-mentored, hands-on participation in
one or more funded CIH-relevant research projects; 3) coursework in concepts and practices of a wide range
of CAM therapies and models of integrative care; 4) interaction with fellows and colleagues from a wide variety
of training backgrounds and interests, thus cultivating appreciation of varying CAM research perspectives; 5)
strengthening skills in presentation, writing, and analysis of others’ work, amid strong collegial support; and 6)
training in practical academic skills, including grant preparation, teaching methodology and dissemination.
Key program elements are: a) targeted recruitment of inspired multidisciplinary postdoctoral trainees from
both conventional and CAM backgrounds, committed to CIH research; c) recruitment of ethnically diverse,
highly motivated pre-doctoral students, who will be closely matched with CIH research mentors; d) early and
sustained interaction of trainees with research and career mentors; d) early, sustained focus on productivity
and collegiality via a weekly 1.5 hour CIH Fellows Core Seminar, co-led by CIH Research Education Faculty
(CREF) and senior post-doc trainees; e) CIH education via CAM/IM practitioner lecture series and exposure to
CAM/IM clinical activities; f) skillful utilization of UNC’s highly regarded training resources in biostatistics,
clinical, and health services research, with guidance from experienced faculty mentors in research design,
implementation, data interpretation, results presentation, research ethics, teamwork and career development.

Public health relevance
PROJECT NARRATIVE As the U.S. public expands its use of complementary, alternative and integrative health (CIH) modalities, there continues to be an important need for well-trained researchers to investigate CIH safety, efficacy, and effectiveness, as well as to explore implementation strategies for integrating effective CIH therapies into health care practice. The UNC Research Training Fellowship in Complementary and Integrative Healthcare, now in its second decade, will continue to meet the need for rigorous, interdisciplinary training of future leaders in CAM and integrative-healthcare research. The program will train young investigators in clinical research methods in mind-body and natural products research, with emphasis on high-impact research that can facilitate increased access to CIH for at-risk populations and conditions.